Clinical Support Services for the NIAMS Intramural Research Program

This project has provided research infrastructure support for FY25 for the clinical protocols listed below. These protocols serve a variety of research needs for investigators in the NIAMS Clinical Research Program (CRP).

IRB # Short Title (DA) = Data Analysis Only PI
94AR0066 Natural History SLE (Lupus) HASNI
96AR0102 Dermatology Teaching Protocol (closed mid-2024) COWEN
96AR0097 Specimen Acquisition from Healthy Volunteers KONG
03AR0173 Natural History JDM KIM
03AR0131 Genetic Determinants in AS-Long (DA) COLBERT
04AR0205 Spinal Fusion in Ankylosing Spondylitis (DA). COLBERT
06AR0198 UVR/UVA Phototoxicity Testing KONG
11AR0223 Natural History Spondyloarthritis COLBERT
12AR0159 Treatment Effect on Microbiome KONG
12AR8001 Compassionate Use JAGA (DA) KIM
13ARN185 Histopath of Merkel Cell Carcinoma BROWNELL
13ARN024 Merkel Cell Specimens BROWNELL
13AR0056 STARA, TNF IN RA (DA) COLBERT
14AR0200 Vasculitis Natural History GRAYSON
15ARN010 Orthopedic Procedures Medicare (DA) COLBERT
15AR0060 PPAR-SLE (DA) KAPLAN
15AR0144 Dermatology Biospecimens KONG
15AR0165 Natural History Melorheostosis GUPTA
18AR0081 Natural History sJIA, Still’s disease OMBRELLO
20AR0032 Glucocorticoid Genomics SLE (DA) FRANCO
000207 SAD-COD, Covid-19 Natural History KAPLAN
000602 Novel tissue biomarkers in Lupus Nephritis KAPLAN
000682 IFN-CVD, Anifrolumab in Lupus KAPLAN
000827 Natural History Alopecia (DA) CASTELO-SOCCIO
000894 Myositis Natural History MAMMEN
IRB001700 Gusacitinib in SLE Clinical Trial HASNI
IRB002085 PMS, Paraspinal Muscle Sarcopenia COLBERT